Core A: Administrative

ABSTRACT: CORE A (ADMIN)
The Administrative Core proposes to provide centralized administrative management and strategic oversight
of integration of the OPC-SURVIVOR Program.
The administrative scope of work of Core A includes:
• budget oversight and administration,
• monitoring and reporting of Program, Project, and Core milestones,
• NCI communications,
• clerical and materials management for the Program,
• centralized file management for the Program,
• organization and communications with Scientific Advisory Board (SAB) including an External Advisory
Committee (EAC) and engaged Patient Research Partners,
• planning, organization and documentation of Program meetings and all investigators annual retreat, and
• communications hub for the investigators.
Aside from Program administration, Core A serves the critical role of overseeing scientific quality and integration
of the Program. Drs. Hutcheson, Lai, and Fuller, as MPI of the OPC-SURVIVOR Program, in consultation with
the SAB, Project Leads, and Core Leads will be responsible for providing overall direction to the integration,
quality, scientific progress, and operations of the Program. Through iterative review of Projects and Core
resource groups bi-annually administered in Core A, the MPIs will promote integration, stewardship, and help to
prioritize resources and scientific agendas. Core A will provide investigators clear lines of scientific and
administrative communication, aid in resource allocation to optimize integration and progression of the proposed
Projects and facilitate resolution of problems and barriers that affect the overall Program’s progress.

Public health relevance
NARRATIVE: CORE A (ADMIN) The purpose of the Administrative Core (Core A) is to provide centralized administrative management, communications hub between Program components, financial oversight and budget administration, clerical and materials management, and compliance with NIH reporting and study conduct for all Projects and Cores. This Core will strive to promote the highest level of integration between the Program components and ensure seamless interactions by facilitating internal and external communication and collaboration between the Investigators and Scientific Advisory Board.